Enhancing alcohol use disorder recovery by capturing the dynamics of psychological well-being in daily life

Project Summary/Abstract
In the alcohol field, the lack of consistent and robust assessment of psychological well-being (PWB) is
problematic considering recent NIAAA recommendations that improvements in PWB should be recognized as
important to the alcohol use disorder (AUD) recovery process, alongside drinking reductions.1–3 PWB,
conceptualized as perceived enjoyment and fulfillment with life,4 is a critical element of health and functioning.5
Unfortunately, indices of PWB are seldom incorporated into primary clinical outcomes for AUD,2,6–8 despite
clients having goals related to PWB such as returning to work, developing more meaningful relationships, and
living more fulfilling lives.9,10 Research that does consider PWB-related outcomes varies considerably in how
PWB is operationalized, ranging from a single positive marker (e.g., life satisfaction, self-esteem)11–13 to the
absence of negative markers (e.g., mental health disorder symptoms).14 Yet, prominent positive psychological
frameworks and measures contend that PWB (1) is multidimensional, consisting of Positive affect,
Engagement, Relationships, Meaning, and Accomplishment (PERMA),15–17 and (2) changes dynamically over
time in day-to-day life.18 To date, there has been no systematic effort to apply comprehensive and valid
assessments of PWB in daily life, such as PERMA, among individuals in AUD recovery. Such an approach
would help center the field on multidimensional assessment of PWB, thereby aligning PWB theory with daily-
life measurement in addiction science.
The proposed research will address the need to better understand and assess PWB in daily life during
AUD recovery by combining baseline measures and ecological momentary assessments (EMA) of momentary
PERMA (mPERMA), a comprehensive, validated, and theoretically-aligned measure of PWB in daily life from
the positive psychology literature, among a community-based sample of adults in AUD recovery. First, this
study will use multilevel modeling to test recovery duration, alcohol problem severity, and personal background
characteristics (e.g., age, sex, race/ethnicity, sexual orientation, socioeconomic status) as baseline predictors
of PWB level and variability in daily life as assessed by mPERMA (Aim 1). Second, group iterative multiple
model estimation (GIMME) will be utilized to investigate group-, subgroup-, and individual-level temporal
patterns of relationships among PWB dimensions and negative affect, craving, and alcohol use assessed via
EMA in daily life (Aim 2). Study findings have the potential to provide a foundation for future research to assess
PWB dynamics in daily life among individuals with AUD, and to inform novel personalized intervention efforts
aimed at both improving PWB and curbing harmful alcohol use.

Public health relevance
Project Narrative This project will utilize the Positive affect, Engagement, Relationships, Meaning, and Accomplishment (PERMA) model as a comprehensive measure of momentary psychological well-being (PWB) in daily life among adults who are in alcohol use disorder (AUD) recovery (e.g., cessation of heavy drinking and remission from DSM-5 AUD). Specifically, this project will test baseline predictors of momentary PERMA (mPERMA; e.g., recovery duration, alcohol problem severity, and personal background characteristics) and investigate shared and person-specific dynamic processes among PWB dimensions and negative affect, craving, and alcohol use assessed via ecological momentary assessment in daily life. Study findings have the potential to provide a foundation for future research to assess well-being dynamics in daily life among individuals with AUD, and to inform personalized intervention efforts aimed at both improving well-being and curbing harmful alcohol use.